Regulation of infectious spore formation in the fungal pathogen Coccidioides posadasii

SUMMARY
The human fungal pathogen Coccidioides causes Valley Fever, a treatment-refractory and sometimes deadly
disease prevalent in arid regions of the western hemisphere. Patients contract the disease by inhaling fungal
spores from soil. Understanding Coccidioides behavior in the environment is thus key to public health measures
for Valley Fever prediction and prevention. We propose a first-ever molecular study of the environmental life
cycle of Coccidioides toward this end. Our preliminary work has shown that Coccidioides preferentially makes
infectious spores in dry conditions. We now want to know how. We apply experimental- and computational-
genomic approaches to dissect desiccation response in Coccidioides outside the host. The rich data sources we
generate will pinpoint candidate genes underlying spore formation and will also position us to discover other
environmentally-triggered phenotypes in Coccidioides. Our work will open a new wing of the research literature
focused on the molecular basis of Coccidioides disease transmission from the environment.

Public health relevance
NARRATIVE The disease Valley Fever is caused by inhalation of a fungus, Coccidioides, from soil in desert regions of the southwestern US. Public health interventions to limit Valley Fever risk rely on an understanding of how and when Coccidioides adopts its infectious forms in the environment, which has remained largely out of reach to date. We will use a genomic approach to investigate the molecular basis of the environmental life cycle of Coccidioides.